Predictive Modeling of the EGFR-MAPK pathway for Triple Negative Breast Cancer Patients

The EGFR-MAPK pathway is a key signaling pathway in human Triple Negative Beast Cancers (TNBC). We
propose to leverage genomic and proteomic data from a rich animal model system, and 2 human clinical trials,
to build predictive models of the EGFR-MAPK signaling pathway activity for TNBC patients. The heterogeneity
of TNBC has hindered previous development of predictive pathway-based computational models because
most approaches are based on experimental data from a single cell line or animal model that is then
extrapolated to fit multiple tumor subtypes. Our approach is to use a diverse experimental model system that
reflects the heterogeneous disease subtypes, and then use two distinct and complementary methods to build
the computational model. We will simultaneously use mechanistic and statistical modeling approaches, at a
variety of scales, that incorporate data from drug treated tumors and cell lines, assayed for gene expression,
DNA copy number, DNA mutations, and protein kinome activity. Lastly, we will test these computational
models on human tumors to evaluate their predictive performance.

Public health relevance
Project Narrative Breast cancer is not one disease, but instead, represents multiple diseases. Each of these unique subtypes requires a different therapeutic approach, thus, determining which new drugs will benefit each disease subtype is critical. To address this need, we are focusing on one of the most therapeutically difficult to treat breast cancer subtypes, namely Triple Negative Breast Cancers (TNBC). We also propose to develop a mathematical representation of a key growth regulating pathway (i.e. EGFR-MAPK) that will predict its activity in TNBC patients, and thus could be used to guide therapies to those patients who have this pathway active within their tumors. We will ultimately test our predictive model on human tumors coming from clinical trials, and if successful, we will have developed a new biomarker for guiding TNBC patient treatments through the use of objective mathematical models